Clinical biomarker for early prediction of chemotherapy-induced peripheral neuropathy

Project Summary / Abstract
Chemotherapy induced peripheral neuropathy (CIPN) is a major side effect of oxaliplatin, a key drug in 1st
line regimens for treating colorectal cancer. Dose-limiting CIPN prevents >25% of patients from receiving full,
maximally effective dose of oxaliplatin. In addition, 10-40% of patients receiving oxaliplatin-based therapy for
colorectal cancer with develop chronic CIPN, which is painful, impairs quality of life, and is associated with
higher opioid use rates. Approaches for CIPN prevention have not yielded meaningful success.
A biomarker that can help with early prediction of CIPN will be a major facilitator of shared decision making
(i.e. changing chemotherapy intensity, frequency, or type) to prevent CIPN, and in stratifying patients to
targeted clinical trials for CIPN prevention. To that end, we have recently characterized the Allo-ColdTM method
for early prediction of CIPN, based on dynamic quantification of cold hypersensitivity. In preliminary studies,
the method demonstrated promising sensitivity and specificity. It is non-invasive, scalable, and has a potential
to be readily implementable, including in low-resource settings.
Our main goal for this Phase I STTR proposal is to develop and test a user-centered mobile health system
prototype for collecting, storing, aggregating and processing patient-reported data on palmar cold sensitivity to
predict CIPN.
In Aim 1, we will develop the Allo-Cold mobile health technology prototype using a user-centered design
approach. We will use three-tier architecture to develop the patient user interface, data management and
storage, and data logic components of a mobile app for CIPN risk prediction. We will iteratively test and refine
the prototype. We will conduct interviews with cancer patients for feedback on prototype acceptability, and with
clinicians to assess implementation barriers.
In Aim 2, we will demonstrate adherence and predictive performance of Allo-Cold system in patients
undergoing oxaliplatin-based chemotherapy. Twenty-four patients with stage III/IV colorectal cancer
undergoing oxaliplatin-based therapy will use Allo-Cold, and self-report cold pain and cold unpleasantness
daily for 10 weeks (5 cycles) of chemotherapy. We will determine patient adherence and the performance of
our predictive algorithm in predicting dose-limiting CIPN.
In this Phase I STTR proposal, we expect to determine the feasibility of the Allo-Cold system by confirming
its usability, adherence, and predictive performance in the context of oxaliplatin-based therapy for colorectal
cancer. Phase II STTR proposal will focus on completing full clinical and analytical validation of Allo-Cold as a
predictive biomarker for CIPN, toward FDA approval and subsequent commercialization.

Public health relevance
PROJECT NARRATIVE (PUBLIC HEALTH RELEVANCE) Chemotherapy-induced peripheral neuropathy (CPIN) is a major painful and dose-limiting complication of oxaliplatin, a life-saving drug for colorectal cancer. In the proposed studies, we will test a novel non-invasive technology, Allo-Cold, for early prediction of CIPN, and determine its feasibility and performance characteristics. This technology, be predicting CIPN risk, can help shared decision making to avoid or prevent CIPN, and thus minimize pain, quality of life impairment, and need for opioid medications in patients with colorectal cancer.